Medical Scientist Training Program

At a time when foundational scientific knowledge is expanding rapidly, there is a critical need to invest in training the next generation of physician-scientists capable of translating scientific discovery into improved patient care. Clinician-scientists serve as vital links between advances in disease pathobiology and innovations in clinical practice. The University of Illinois Chicago (UIC) Medical Scientist Training Program (MSTP) offers a combined MD/PhD training pathway designed to cultivate highly skilled physician-scientists. Established in 2003 and NIH-funded for over 15 years, the UIC MSTP integrates rigorous scientific research training with clinical education, mentoring, and career development. The program’s primary objective is to provide a comprehensive, well-integrated training experience that prepares graduates to lead biomedical research efforts and advance evidence-based clinical care. Trainees explore disease mechanisms at the molecular and cellular level through approaches that include ‘omics’ technologies, whole animal models, clinical studies, and translational research. The MSTP environment is rich with interdisciplinary training opportunities provided by accomplished clinician-scientists and scientist mentors with strong records in research and mentoring.
Currently, 102 students are enrolled in the program, selected through a mission-driven admissions process. The entering cohort has five-year average metrics of 3.7 GPA and 514 MCAT, with a matriculation rate of 4% from an average applicant pool of 318. The average time to complete both degrees is 8.0 years, and graduates consistently match into competitive residency programs. Recent programmatic enhancements include: the creation of a structured advising house system to support longitudinal mentoring; development of a new Graduate Education in bioMedical Sciences (GEMS) program with interdisciplinary tracks; expansion of research opportunities through nontraditional PhD pathways; structured mentor training on research core competencies; and implementation of a comprehensive program evaluation system to provide continual feedback on advising, educational, and administrative components.
We are confident that the UIC MSTP will continue to develop physician-scientists equipped to advance biomedical discovery and improve patient outcomes. We are requesting continued funding for 10 trainee positions to support this mission.

Public health relevance
Project Narrative This program produces physician scientists who have both MD and PhD training, i.e., who receive both degrees at the completion of the program. MD-PhD graduates have deeper perceptions of medical significance in biology than do scientists without medical education, more comprehensive understanding of the limitations in medical practice, and greater ability to transfer basic scientific advances toward patient care advances. Thus, MD-PhD graduates are positioned to identify and pursue interdisciplinary approaches to important biomedical problems, and to help bridge the basic and clinical sciences.